Mechanism for Programming of Offspring Adiposity by Maternal PM2.5 Exposure

ABSTRACT
Considerable epidemiological studies reveal that maternal exposure to ambient fine particulate matter
(PM2.5) poses a significant risk for obesity to the child. In animal models, we and others corroborate the adverse
programming of offspring adiposity by maternal PM2.5 exposure and implicate the offspring’s hypermethylated
and thus down-expressed Leptin in this adverse programming. In contrast, few published studies have tested the
maternal pathogenesis for this adverse programming. In order to develop effective intervention strategies that
may benefit both the mother and child, we propose to unravel its maternal pathogenesis using our unique
genetically-modified animal models and state-of-the-art PM2.5 exposure technique. Through a synthesis of both
published and preliminary data, we hypothesize that maternal PM2.5 exposure programs offspring Leptin
expression and thus adiposity via maternal pulmonary inflammation and ensuing oocyte down-expression of
Tet2, and propose to thoroughly test this hypothesis through pursuing three discrete yet linked aims: Aim 1: To
model the dose- and composition-dependencies for the adverse programming of offspring adiposity by maternal
PM2.5 exposure. Aim 2. To determine whether maternal PM2.5 exposure programs offspring adiposity through
maternal oocyte down-expression of Tet2 and subsequent offspring down-expression of Leptin. Aim 3: To
determine whether pulmonary inflammation induced by PM2.5 exposure elicits maternal oocyte disturbance and
subsequent programming of offspring adiposity. By revealing the critical pathogenesis, this project is expected to
provide a strong scientific framework for understanding of and developing interventions for the adverse
programming of offspring adiposity by maternal PM2.5 exposure.

Public health relevance
PROJECT NARRATIVE (RELEVANCE) Obesity is an uncontrolled global epidemic. Maternal exposure to ambient fine particulate matter (PM2.5) correlates with offspring obesity. We and others have shown the adverse programming of offspring adiposity by maternal PM2.5 exposure, explaining this association. Using unique knockout and transgenic mouse models, this project will determine the unexplored maternal pathogenesis for this programming, aiming to develop effective intervention strategies that target the maternal pathogenesis and thus may benefit the health of both the mother and child.